Molecular Aspects of Oral Plaque Formation

Abstract
Polymicrobial infections are inherently more complex than monospecies infections, and this complexity has
been a significant barrier to both a fuller appreciation of pathogenic mechanisms, and to the development of
effective measures to control or prevent the disease. Periodontal diseases typify polymicrobial diseases, and
are among the most common infections of humans. Although certain organisms, such as Porphyromonas
gingivalis, are considered key pathogens, it is the polymicrobial community as a whole that initiates and
drives the disease. Interspecies interactions within communities shape overall pathogenic potential, and
work supported by this project has uncovered a dynamic and multilevel interaction between P. gingivalis
and its community partners. The pathogenicity of P. gingivalis can be constrained by the streptococcal
diffusible metabolite, para-amino benzoic acid (pABA), which is as a precursor of de novo folate synthesis in
the physiologically essential one-carbon metabolism (OCM) pathway. However, as physically integrated
communities develop, interspecies co-adhesion results in suppression of streptococcal pABA production, and
additionally, partner organisms such as Streptococcus gordonii and Fusobacterium nucleatum, enhance
overall community pathogenicity. Sensing of both pABA and interspecies physical contact by P.
gingivalis is transduced through a protein tyrosine phosphorylation signaling circuit. The tyrosine kinase
Ptk1 controls flux through OCM as well as the production of virulence factors, including the gingipain
proteases which can modulate interactions with neutrophils. Indeed, Ptk1 is required for pathogenicity in
both murine abscess and alveolar bone loss models of disease. In this proposal we will define the role of
Ptk1 as a master regulator which can integrate OCM with pathogenicity. In the first Aim we will examine how
Ptk1-mediated phosphorylation of gingipains is necessary for their processing and secretion. We will
determine where non-phosphorylated gingipains remain localized in P. gingivalis and investigate which
components of the type IX secretion system machinery malfunction in the absence of phosphorylation.
Additionally, we will follow post-translational maturation of non-phosphorylated gingipains to uncover the role
of phosphorylation in catalytic removal of the N-terminal peptide, the haemagglutinin domains, or the C-
terminal domain as is required for the assembly of fully activated proteases. In the second Aim, we shall
functionally dissect the contribution of phosphorylation to the activity of the pABA synthesis enzyme PabC, and
decipher a negative feedback loop whereby pABA can inhibit Ptk1. Aim 3 will address the impact of Ptk1 on
the activation state of neutrophils and their potential for tissue destructive responses to P. gingivalis.
Completion of this project will provide novel insights into the context-dependent pathophysiology of P.
gingivalis, which could ultimately be translated into therapeutic strategies designed to target the
community-based pathogenesis that underlies periodontal disease.

Public health relevance
Narrative Diseases caused by mixtures of bacteria are often more serious and harder to treat that those caused by a single organism. Periodontal (gum) diseases are caused by mixtures of microbes that communicate with each other to regulate the level of disease-causing potential of the microbial community. In this proposal we shall study the communication mechanisms that allow periodontal bacteria to increase production of toxic products, become more metabolically active, and resist killing by the host.